Pregnenolone as a Treatment for Cannabis Intoxication

Project Abstract
This project aims to assess the potential of pregnenolone, a signaling specific negative allosteric modulator
(NAM) of the CB1 cannabinoid receptor, to reverse symptoms of cannabis intoxication. As defined by the DSM-
5, cannabis intoxication involves neuropsychiatric symptoms such as anxiety and impaired motor coordination
and physiological symptoms including dry mouth and tachycardia arising shortly after cannabis use. These
symptoms can be distressing and associated with significant clinical complications such as car accidents,
cardiac arrhythmias, and psychotic episodes. Cannabis’ increasing popularity and potency has seen a surge in
emergency room (ER) visits for management of intoxication, yet there are no medications indicated for the
treatment of cannabis intoxication. NAMs of the CB1 receptor—the cannabinoid receptor whose activation by
tetrahydrocannabinol (THC) facilitates intoxication—have shown promise as novel treatments for cannabis
intoxication. Pregnenolone, an endogenous neurosteroid often marketed as a supplement, has been shown to
act as a CB1 receptor NAM specifically attenuating the effects of THC. Preclinical studies demonstrating
pregnenolone’s capacity to treat cannabis intoxication symptoms have led to interest in applying its mechanism
to drug development yet its ability to reverse active intoxication symptoms have not yet been studied in
humans. We will therefore set up a within-subjects, double-blind, placebo-controlled human laboratory study
investigating whether pregnenolone can treat cannabis intoxication symptoms. Healthy, cannabis-naïve
individuals who meet inclusion criteria will be randomized to one of four conditions: cannabis brownie and
placebo capsule, cannabis brownie and 250 mg pregnenolone capsule, cannabis brownie and 500 mg
pregnenolone capsule, and placebo brownie and placebo capsule (all cannabis brownies will contain 25 mg
THC). Following study drug administration, participants will complete questionnaires evaluating subjective
effects (via the Drug Effect Questionnaire), psychotomimetic symptoms (via the Positive and Negative
Syndrome Scale) and cognitive/psychomotor impairment (via a battery of cognitive assessments). Heart rate
will also be assessed. Blood will also be collected at various timepoints for later measurements of serum
pregnenolone, THC, and THC’s metabolites 11-OH-THC and THCCOOH to assess any dose-dependent
effects of pregnenolone on cannabis intoxication. We hypothesize that pregnenolone administration will be
associated with significantly fewer cannabis intoxication symptoms compared to placebo as evidenced by
lower scores on the questionnaires, and that higher levels of pregnenolone will also be associated with fewer
subjective effects and signs of impairment associated with cannabis intoxication. Results from this study will
provide information on whether agents that act as CB1-NAMs can serve as rescue therapies for cannabis
intoxication symptoms, while also giving insights into whether pregnenolone itself could fulfill this role.

Public health relevance
Project Narrative Cannabis intoxication—a DSM-5 syndrome consisting of psychiatric and physical symptoms arising shortly after cannabis use—represents a mounting health concern associated with increasing emergency room visits and complications including acute cardiac arrhythmias and psychotic episodes. The endogenous neurosteroid pregnenolone has demonstrated preclinical evidence of treating cannabis intoxication symptoms by acting as a negative allosteric modulator of the CB1 receptor, whose activation facilitates cannabis intoxication. This present human laboratory study aims to determine if pregnenolone can treat cannabis intoxication symptoms in humans, with results affirming the capacity for negative allosteric modulators of the CB1 receptors to treat cannabis intoxication and suggesting that pregnenolone can act as a therapeutic agent.